The ED.TRAUMA Study: Evaluating the Discordance ofTrauma Readmission And Unanticipated Mortality in the Assessment of hospital quality

PROJECT SUMMARY/ABSTRACT
Trauma is a common, high-risk, and high-cost condition that uniquely affects the health of older adults. In 2017
alone, 4.8 million non-fatal traumatic injuries were reported among older adults aged ≥65 years in the United
States (US), costing hospitals and payers upwards of $66.8 billion (2019 USD) or ~2% of all US spending on
healthcare. By 2050, the number of older adults is projected to rise to 89 million (22.1% of the total US
population). With it is expected to come a parallel increase in the number of older adult trauma patients.
Traumatic brain injury (TBI) and hip fracture are among the most common and debilitating forms of trauma
encountered among older adults, often resulting in long-term functional impairments, nursing home admission,
decreased independence, and shortened life expectancy. Improving outcomes for older trauma patients,
particularly those with severe TBI and hip fracture, is an important national priority.
While external benchmarking has evolved as the preeminent methodology used to compare hospital outcomes
when measuring quality of care, its application among trauma patients is currently limited by a lack of available
post-discharge data and concerns within the trauma community that poorly applied metrics might not be
representative of the complex patients that trauma providers treat and the breadth of adverse outcomes that
trauma patients face. Through this grant and its three specific aims, we propose to build on existing efforts within
trauma to benchmark hospitals. Expanding on data currently limited to in-hospital mortality, we will utilize
longitudinal 100% Medicare fee-for-service claims to study post-discharge outcomes among older adults
hospitalized for: 1) trauma in general, 2) severe TBI, and 3) hip fracture. Aim 1. To quantify the extent of variability
in and potential discordance between trauma mortality and readmission performance profiles. Aim 2. To
ascertain whether there are clusters of hospitals with highly similar and/or highly divergent trauma readmission
and mortality outcomes and identify associated factors. Aim 3. To compare the results of conventional external
benchmarking for readmission with those attained under a model that allows for competing risk.
The findings from this work will lay a foundation on which the continued development of trauma quality
improvement and national health policy benchmarking can build. It will have a major, direct impact on how the
quality of care for older adults is measured and conceptualized, helping to determine the future of clinical care
for one of the most common, high-risk, and high-cost conditions affecting the health of older adults while
simultaneously informing the development of meaningful and strong quality metric models with applications to
both trauma and other non-trauma conditions.

Public health relevance
PROJECT NARRATIVE Trauma is a common, high-risk, and high-cost condition that uniquely affects the health of older adults. Through this grant and its three specific aims, we propose to build on existing efforts within trauma to benchmark hospitals and, thereby, gauge the quality of older adult trauma care by: (1) quantifying the extent of variability in and potential discordance between trauma mortality and readmission performance profiles, (2) ascertaining whether there are clusters of hospitals with highly similar and/or highly divergent trauma readmission and mortality outcomes and identifying associated factors, and (3) comparing the results of conventional external benchmarking for readmission with those attained under a model that allows for competing risk. The findings from this work will have a major, direct impact on how the quality of care for older adults is measured and conceptualized, helping to determine the future of clinical care for older adult trauma patients while simultaneously informing the development of meaningful and strong quality metric models with applications to both trauma and other non-trauma conditions.